The role of lysosomal deregulation in cancer progression

Project Summary
Aggressive metastatic breast cancer is responsible for the deaths of more than 40,000 people per year in the
U.S., despite the best efforts of researchers and clinical oncologists. I have recently discovered a potentially
important mechanism regarding the generation of a unique secretome by breast cancer cells, which makes
an essential contribution to their invasiveness and metastatic capability. Specifically, I have delineated an
intriguing connection between the down-­regulation of Sirtuin 1 (Sirt1), a NAD-­dependent deacetylase, in
aggressive breast cancer cells and the corresponding reduction in the expression of a major subunit of the
vacuolar ATPase (V-­ATPase), which results in the impairment of their lysosomes and consequently, dramatic
changes in their secretome. These changes include a significant increase in the number of exosomes
generated by breast cancer cells, and an enrichment in their ubiquitylated protein cargo. Exosomes are small
(extracellular) vesicles, ~30-­150 nm in size, that contain a wide range of cargo including proteins, RNA
transcripts, microRNA, and even DNA. They function as mediators of intercellular communication and have
been implicated in a number of aspects of cancer progression, including the promotion of chemo-­resistance
and the formation of a pre-­metastatic niche. Because exosomes are also attractive vehicles for the delivery
of therapeutic agents, studies aimed at determining how exosomes are formed and released, as well as
characterizing their functional properties, are being extensively pursued. Thus, these findings now highlight
how aggressive breast cancer cells generate exosomes containing unique cargo, which contribute to the
metastatic capability of breast cancer cells. I further discovered that the down-­regulation of Sirt1 in breast
cancer cells results in a significant increase in the secretion of soluble hydrolases, in particular, cathepsins.
Collectively, these components making up the secretome of aggressive breast cancer cells give rise to a
marked enhancement in migratory and invasive activity. In the F99 phase of this application, these discoveries
will be extended by determining the underlying mechanisms by which the down-­regulation of Sirt1 in
aggressive cancer cells leads to a reduced expression of the V-­ATPase (Aim 1). A particular emphasis will
be to identify the Sirt1 substrate that is directly responsible for regulating the stability of the RNA transcript
encoding one of the major subunits of the V-­ATPase. In the K00 phase of the proposal (Aim 2), a
research/training environment will be sought to develop animal models that will further establish the functional
connection between Sirt1, the v-­ATPase and lysosomal function, and demonstrate how this contributes to the
metastatic state. The ultimate goal of my studies will be to highlight strategies that alter these connections in
a manner that leads to new anti-­cancer therapies.

Public health relevance
Project Narrative The metastatic process continues to be a devastating outcome of aggressive cancers. Small extracellular vesicles, known as exosomes, have been heavily implicated in this process, as have other components of the secretome of aggressive cancer cells, such as cathepsins. I have recently identified novel mechanisms by which aggressive cancer cells give rise to a unique secretome, that increases their metastatic potential, and I plan to further explore and delineate these mechanisms in this F99/K00 research proposal, with the ultimate aim of developing new therapeutic strategies against metastatic cancers.